Artificial sweeteners and cardiovascular disease

Project Summary
This application is entitled “Artificial sweeteners and cardiovascular disease”. The proposed studies investigate
whether low calorie, non-nutritive sweeteners (NNS’s), and commonly employed artificial sweeteners, contribute to
the development of cardiovascular disease (CVD) through enhanced vascular inflammation, atherosclerosis and
platelet reactivity and thrombosis potential. Our overall studies are based on a combination of both clinical
observations, and mechanistic cellular and animal model studies. Using untargeted mass spectrometry as an initial
discovery platform, we identified circulating levels of the endogenous metabolites erythritol, xylitol and other polyols
as being associated with incident (3yr) risk for major adverse cardiovascular events (MACE = myocardial infarction
(MI), stroke or death). Subsequent preliminary studies (with erythritol and xylitol) confirm these initial clinical
associations, and a variety of animal model and other investigations suggest a role for these polyols in directly
promoting vascular inflammation and thrombosis potential in animal models of disease. It is notable that a growing
body of epidemiological data questions whether artificial sweetener use provides the presumed added benefits
(weigh reduction, improved diabetes control). And the present studies significantly add to the growing concern
about artificial sweeteners and cardiometabolic diseases.
Erythritol, xylitol and other polyol NNS have more recently been widely adopted by the food industry as artificial
sweeteners. Consequently, supra-high physiological levels are now routinely experienced by consumers of foods
where these agents are abundant components (e.g. keto-friendly foods, low-carb foods, and zero-calorie foods),
amplifying the urgency of the proposed studies. We propose to investigate whether low calorie NNS like erythritol,
xylitol, their numerous structural isomers also being explored as commercial artificial sweeteners, and commonly
employed/consumed artificial sweeteners, might inadvertently be contributing to heightened CVD risks in the very
subjects most vulnerable to CVD. Our proposed studies are multidisciplinary. They are based on human clinical
observational studies, from which numerous mechanistic investigations involving cell-based assays and preclinical
models of vascular inflammation, vascular injury, atherosclerosis and thrombosis are proposed. Successful
completion of the proposed studies will further advance our knowledge of how polyols, artificial sweeteners and
other NNS’s may impact vascular health.

Public health relevance
Project Narrative Polyols are endogenously produced as part of intermediary metabolism. Some of these polyols are used commercially in processed foods at supra-high physiological levels, yet in recent studies have been shown to be associated with increased vascular and atherosclerotic disease risk. We plan to investigate mechanisms involved and the potential contribution of polyols and artificial sweeteners to cardiovascular disease.